Uncovering the Role of Dietary Fat and Protein in Glycemic Physiology in Pregnancy and in Gestational Diabetes

PROJECT SUMMARY/ABSTRACT
The first-line treatment of gestational diabetes (GDM), a disease rising in prevalence, is dietary therapy, yet the
optimal diet for these patients is unknown. Guidelines have focused on carbohydrate restriction in GDM, with
some evidence suggesting improved maternal and fetal outcomes, yet there is concern that low carbohydrate
diets may have adverse fetal consequences. Research evaluating different nutritional macronutrients,
specifically protein and fat, in pregnancy and GDM is lacking. The objectives of the proposed research projects
are to understand the impact of dietary fat and protein on insulin physiology and glycemia in pregnancy and in
GDM with the goal of discovering the optimal diet for women affected by GDM. The applicant will utilize data
from a prospective longitudinal observational study of glucose metabolism in pregnancy to investigate the
effects of dietary protein and fat exposure on insulin physiology in pregnant women. The applicant will also
evaluate the acute effects of protein and fat on glycemia in women with GDM in an interventional cross-over
randomized trial of two isocaloric breakfast meals with identical carbohydrate content and varying protein and
fat content (high protein/low fat, low protein/high fat). The aims of this project are:
1. Define the relationship of dietary fat and protein with insulin physiology in pregnant women. The first
hypothesis is that diets high in fat will lead to reduced insulin sensitivity as compared to diets low in fat;
the second hypothesis is that diets high in protein will lead to increased insulin secretion (adjusted for
insulin sensitivity) as compared to diets low in protein.
2. Prospectively test the acute effect of fat and protein on post-prandial glycemic response in women with
GDM. The hypothesis is that the high protein/low fat meal will lead to lower peak post prandial glucose
levels than the high fat/low protein meal.
The results of these studies will determine the impact of protein and fat on insulin physiology and glycemia in
pregnant women and in GDM and thus have the potential to inform clinical dietary recommendations in GDM.
The training plan includes dedicated mentorship by Dr. Ellen Seely MD (sponsor) and Dr. Camille Powe MD
(co-sponsor), each offering expertise tailored to the applicant’s needs and goals. Additionally, the applicant will
complete formal training in biostatistics, nutrition and clinical research through the Harvard Catalyst
Clinical/Translational Science Center, the Harvard T.H. Chan School of Public Health, the Massachusetts
General Hospital Division of Clinical Research, and the National Institutes of Health Office of Behavioral and
Social Sciences Research. These activities will provide the applicant with the tools critical for a career as an
independent clinical researcher in the field of nutritional and lifestyle approaches to GDM.

Public health relevance
PROJECT NARRATIVE The projects proposed in this award application aim to understand the impact of understudied dietary macronutrients, protein and fat, on glucose physiology in pregnancy and in women with gestational diabetes (GDM), a disease with rising prevalence that is associated with adverse maternal and fetal outcomes. The first- line treatment of GDM is dietary modification, yet there is no consensus on the optimal diet for these women. Better understanding of the impact of protein and fat on insulin physiology and glycemia in pregnancy and in GDM has the potential to influence management of this disorder by altering dietary recommendations.